Toward ultrasound brain imaging via machine-learning-extracted skull profile and speed of sound

Project Summary
Transcranial ultrasound could facilitate a broad variety of applications in brain imaging, e.g., functional imaging,
intracerebral hemorrhage detection, brain perfusion evaluation, and stroke diagnosis. Ultrasound has the intrinsic
advantages of being real-time, portable, widely available, noninvasive, and free from ionizing radiation. Thus,
transcranial ultrasound imaging could potentially play a unique role in a time-sensitive and dynamic environment
where X-ray computed tomography (CT) and magnetic resonance imaging (MRI) are unavailable. For instance,
transcranial ultrasound has significant potentials in the initial assessment of traumatic brain injury during the
transportation of patients to the hospital, and in bedside monitoring of brain physiology for stroke patients in an
intensive care unit. Despite its promising potentials, the use of transcranial ultrasound imaging has been limited,
largely because adult human skulls cause severe phase aberration, leading to highly degraded ultrasound
images. Phase aberration from the skull can be accurately corrected if the speed of sound (SOS) and profile
(i.e., thickness distribution) of the skull are known a priori. The skull profile and SOS can be estimated by CT,
currently the gold standard approach for treatment planning. The CT-based approach is far less appealing,
however, for ultrasound imaging purposes because of the additional CT scans that involve ionizing radiation and
image co-registration. We propose a real-time pulse-echo ultrasound approach to estimate the skull profile and
SOS using deep learning (DL) methods with ultrasound radiofrequency (RF) signals backscattered from the skull.
The proposed approach rests on the scientific premise that these RF signals contain extremely rich information
of the interaction between ultrasound and skulls, and the information of skull profile and SOS is encoded in the
backscattered signals in a convoluted way that cannot be fully described by simple physical models. We
hypothesize that DL, a subclass of machine learning (ML), is capable of automatically and rapidly extracting skull
profile and SOS from RF signals with sufficient training. The objective of this Trailblazer R21 application is to
develop and validate DL methods for extracting the human skull profile and SOS, with the following aims. Aim 1.
In silico study: Develop and evaluate DL-based skull profile and SOS extraction algorithms using synthetic data.
Aim 2. Experimental study: Evaluate DL algorithms’ performance in skull profile and SOS extraction using
experimental data. Aim 3. Pilot imaging study: Evaluate DL algorithms’ performance in transcranial imaging.
Successful completion of this study will facilitate the transcranial application of both conventional (e.g., B-mode
imaging, blood flow imaging, and contrast-enhanced ultrasound) and emerging ultrasound imaging methods (e.g,
super-resolution imaging and photoacoustic tomography). Although the current application focuses on brain
imaging, our method can be extended to phase aberration correction for ultrasound-based brain treatment,
neuromodulation, and ultrasound imaging of other organs where phase aberration exists.

Public health relevance
Project Narrative Transcranial ultrasound could facilitate a broad range of applications in imaging and therapy, such as functional imaging, intracerebral hemorrhage detection, brain perfusion evaluation, cerebrovascular disease diagnosis, neurological disorder treatment, and neuromodulation. Despite its promising potentials, transcranial ultrasound imaging remains difficult and limited largely because skulls cause severe phase aberration, leading to highly degraded ultrasound images. This project aims to address this major limiting factor by developing new machine-learning-based methods to extract the skull profile and speed of sound directly from backscattered ultrasound signals and therefore enable accurate phase aberration correction.